A Bioengineered Model for Deciphering Lymphatic Dysfunction in Inflammation

PROJECT SUMMARY
Lymphatic vessels (LVs) are central in maintaining fluid homeostasis, regulating host immunity, and
transporting dietary fat and neuronal waste. All these functions are governed by lymphatic drainage, a
transport of interstitial fluid and immune cells into the lymphatic system through initial LVs and collecting LVs.
The initial and collecting LVs have different structures and roles in maintaining lymphatic drainage. The initial
LVs have permeable cell-cell junctions and are ready to uptake interstitial fluid and cells; by contrast, the
collecting LVs are less permeable, so that the collecting LVs can transport ‘lymph’ to lymph nodes without
leaking. Impaired lymphatic drainage contributes to LV-related human diseases, such as lymphedema,
immune dysfunction, fibrosis, obesity, cancer, Alzheimer’s disease, etc. While little is known about why LVs
become dysfunctional, clinical studies reveal that inflammation is one of the leading contributors to the
lymphatic dysfunction. Mechanisms of how inflammation affects both initial and collecting LVs making them
dysfunctional are unclear, because in our current experimental models, including animal models, we often
cannot decouple multifactorial inflammatory factors in the initial and collecting LVs. Since two-dimensional
cell culture has failed to recapitulate three-dimensional (3D) tissue architecture of lymphatics, researchers
have developed 3D in vitro models of LVs, demonstrating lymphatic sprouting, lymphatic network formation,
LV permeability, and LV interactions with surrounding cells. However, these previous models have not
created 3D lymphatics with LEC junctions enabling controlled drainage, valve formation, or physiological
inflammatory response. Also, they have not considered the distinct roles of initial and collecting LVs. In this
proposal, we will establish a bioengineered in vitro 3D lymphatic vascular system, including both initial and
collecting LVs, and determine how inflammatory conditions make the initial and collecting LVs dysfunctional.
In Aim 1, we will establish collecting LV-on-chip, considering (i) tightened cell-cell junctions, (ii) luminal valves,
and (iii) mural cell coverage (Aim 1.1). Next, we will combine the collecting LVs with the initial LVs and
demonstrate fluid and immune cell transport through these LVs in the normal condition (Aim 1.2). In Aim 2,
we will determine the effects of inflammatory conditions by using inflammatory cytokines that are relevant to
lymphatic dysfunction on the initial and collecting LVs and overall lymphatic drainage (Aim 2.1). Next, we will
identify new targets to reverse the lymphatic dysfunction by screening pathways of lymphatic vascular
mechanotransduction (Aim 2.2). We will then validate the mechanisms and targets in an in vivo skin
inflammation model (Aim 2.3). In summary, we will develop a new bioengineered model of 3D lymphatic
vascular system and fluid/immune cell transport through the initial and collecting LVs and provide a unique
in vitro platform to address how the LV dysfunction occurs in inflammation, and identify new therapeutic
targets to reverse the dysfunction.

Public health relevance
PROJECT NARRATIVE Lymphatic dysfunction is closely related to major human diseases, including lymphedema, immune dysfunction, cancer, metabolic disease and neurodegenerative disease. This project will establish a bioengineered 3D lymphatic vascular system in vitro, including both initial lymphatic vessels and collecting lymphatic vessels. We will use this platform to 1) examine fluid and immune cell transport through the distinct lymphatic vessels, and 2) evaluate inflammatory effects on those lymphatic vessels and discover new targets to reverse lymphatic dysfunction in inflammation, which will be validated in a mouse skin inflammation model.